Using place-based education to engage Bronx high schoolers and teachers in health disparity research

Project Summary/Abstract
A critical mass of health researchers is needed to reduce health disparities affecting minority and
underserved communities. Bronx residents’ experience health disparities with special attention on
diabetes, mental health, STDs, asthma, sleep disorders, and injury. COVID-19 exacerbated Bronx’s
health disparities. Lehman College has a long-standing mission to educate students from diverse
backgrounds and is uniquely poised to address health disparities. This current project will enhance
Lehman’s Science and Technology Entry Program – STEP and will target Bronx High School Marie
Curie School for Medicine, Nursing, and Health Professions (Marie Curie). The overall goal of this
community health training modules using a place-based approach (PBE) for Marie Curie’s high school
teachers on health disparities research-related topics of importance to the Bronx. The focus is to design
professional development modules on the principles of community health and health disparities
research. One cohort of teachers will receive training on health disparities topics and theories and
incorporate these topics into Unit Plans using place-based education approaches. These plans will be
implemented through the Lehman STEP program for Cohort 1 of students in Year 2. In the summer Year
2 modules will be revised and adjusted based on teacher’s and student’s feedback and re-piloted in
cohort 2 in Year 3.Phase 2 has two aims: Specific Aim 2: Create a high school-to-college pathway for
Bronx high schoolers by providing in-classroom training and summer practicum research experiences
with a near-peer college student to motivate studies in biomedical, behavioral and data science careers;
and Specific Aim 3: Create community health forums with public health and health services
practitioners and scientists to identify successful career pathways, challenges and career transition
nodes of the ‘biomedical workforce in the Bronx and New York City. The focus of Phase 2 is to foster
research methods with a health disparities perspective and an intersectionality approach to data among
two cohorts of high schoolers. Students will collaborate with a near-peer Lehman college student as a
tutor. Participants will receive in-class education in tailored quantitative reasoning and analyses and
English composition college level courses combined with summer research practicum boosters. Student
and teachers will also participate in health forums with public health and health services practitioners to
learn about biomedical careers and pathways. This project is relevant to NIH’s mission to enhance
health and reduce the burden of illness by providing scientific training and mentorship to high schools
that have large populations of underrepresented minorities and underprivileged students.

Public health relevance
Project Narrative The Bronx has a long history of experiencing health disparities including diabetes, asthma, STDs/HIV, sleep disparities and more. Underserved communities urgently need health investigators that understand their communities. This project develops educational activities for pre-college Bronx students to pursue studies in research using a place based educational approach.